DATA, IMAGES SHARED; RESPONSES TO RESEARCHER QUESTIONS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Investigators from around the world see images produced at the Center and gain insight into our work through our web site, publications, and presentations at technical meetings. We share data to support their research, as requested. See examples listed below.